Novel, Targeted Method for Bacteriophage Purification

PROJECT SUMMARY
The fields of gene therapy and bacteriophage therapy are rapidly expanding and show promising
potential for treating genetic disorders and antibiotic resistant bacterial infections, respectively.
To meet these needs, improved high throughput and high affinity viral purification methods will be
required. Current high throughput viral purification methods mainly consist of resin-based
chromatography coupled with multiple filtration steps. Chromatography-based methods often lack
specificity for the particular virus target. For example, the commonly used ion exchange resins
are not able to separate contaminants sharing similar surface net charges to the virus particles.
Selection of mixed virus varieties such as viruses of different serotypes cannot be achieved with
chromatography methods. Affinity-based resin chromatography products targeting viral vectors
exist but are expensive or not suitable for large-scale purification. Additionally, they involve
coupling a binding entity to resin, which presents several disadvantages, including leaching of the
affinity ligand from the chromatography support or the ligand co-eluting with the virus particles.
Thus, improved methods for simple, rapid, and scalable purification of viral vectors are needed to
serve both the small-scale research community and large-scale industrial production. Bondwell
Technologies proposes to develop a novel purification system for large biomolecules, such as
viral vectors. The unique qualities of our functionalized biomaterial provide tremendous versatility
and addresses the current limitations of small- and large-scale viral purification. During this
proposed Phase I effort, we will first functionalize our biomaterials with an entity capable of
specifically recognizing a viral target. We will then test the biomaterial for their ability to bind the
viral target. Finally, we will prepare our biomaterial to be used as a membrane and test its ability
to bind a viral target with different complexities of starting material (e.g., with cellular debris
present).

Public health relevance
PROJECT NARRATIVE The fields of gene therapy and bacteriophage therapy are rapidly expanding and show promising potential for treating genetic disorders and antibiotic resistant bacterial infections. To meet these needs, improved methods for simple, rapid, and scalable purification of viral vectors are required to serve both the small-scale research community and large-scale industrial production. Current methods either lack target specificity, are not suitable for large-scale or are very expensive.